Flow Cytometry Shared Resource

FLOW CYTOMETRY SHARED RESOURCE - PROJECT SUMMARY/ABSTRACT
Flow Cytometry (FC) Shared Resource was established in 2004 to provide ready and affordable access to state-
of-the-art multi-parameter cell analysis and sorting capabilities. This facility is comprised of a large number and
variety of flow cytometry instruments that quantify the fluorescence of individual cells, typically following staining
with specific antibodies. Flow cytometry has become an important tool in cancer research for many different
purposes. Some important applications include the immune profiling of tumor microenvironments and the
phenotyping of cancer cells. Cell sorting by flow cytometry is critical for the purification of cells for genomics,
proteomics, metabolomics, or the isolation of tumor stem cells. This institutional resource serves the entire Yale
School of Medicine (YSM) campus, including Yale Cancer Center (YCC), and thus has a critical mass of users
supporting these large and expensive instruments.
During the most recent funding period, 187 laboratories have used Flow Cytometry. One hundred and seventeen
(53%) are YCC members. This Shared Resource was most widely used by the Cancer Immunology (CI),
Genomics, Genetics and Epigenetics (GGE), and the Cancer Signaling (CSN) Research Programs. The facility
also offers consulting on experimental protocols as well as some wet-bench services that can be performed on
a fee-for-service basis for clinicians who do not have their own laboratory staff. These include sample
cryopreservation, sample staining and data acquisition and/or data analysis. This has proven to be helpful for
clinicians who wish to have correlative studies associated with their clinical trials.
Flow cytometry has multiple applications in cancer research. For example, as the pace of research into cancer
immunology and biologic therapies increases, defining the functional and phenotypic heterogeneity of mixed cell
populations will continue to be a critical technology in cancer research. Flow cytometry is not only essential for
cancer immunology research, but also empowers numerous other types of studies such as oncogenesis, cell
signaling events, preclinical models, the assessment of therapeutic efficacy, gene editing using CRISPR and of
course, cell sorting for genomic and RNA sequencing. Clearly, flow cytometry is vital to several programs within
YCC.
The Specific Aims of the Flow Cytometry Shared Resource are: 1) to provide flow cytometry services that are of
high quality, readily available, and at reasonable cost; 2) to educate the YCC community on the applications of
flow cytometry in medical research; and 3) to collaborate with YCC investigators in the development of new
applications.

Public health relevance
FLOW CYTOMETRY SHARED RESOURCE – NARRATIVE Not applicable.